Increasing SARS-CoV-2 (COVID-19) testing capacity at the Nebraska Veterinary Diagnostic Center

Project Summary/Abstract
The Nebraska Veterinary Diagnostic Center (NVDC) is a full-service veterinary diagnostic
laboratory, is fully accredited by the American Association of Veterinary Laboratory
Diagnosticians, is a member of FDA-CVM Vet-LIRN network, is a National Animal Health
Laboratory Network (NAHLN) Level 1 laboratory, and is a certificated laboratory for National
Poultry Improvement Plan testing. The laboratory processes over 300,000 specimens annually
from a variety of species including livestock, companion animals, poultry, wildlife, and zoo
animals. As part of a collaborative effort to enhance surveillance for SARS-CoV-2 in animals,
more than 3,600 animals diverse animal species were tested in 2022-2023. To increase the
diagnostics testing capacity and capabilities for SARS-CoV-2 in animals, the NVDC is seeking
funds to purchase a digital PCR system. This equipment will enable the NVDC to enhance
SARS-CoV-2 diagnostic testing by allowing extremely sensitive detection of SARS-CoV-2 in
animal specimens. Additionally, the digital PCR approaches allows for quantification of SAR-
CoV-2 genomes in clinical samples, which will help inform clinicians and One Health partners in
assessing virus levels and transmission in animals.

Public health relevance
Project Narrative The NVDC is seeking Capacity Building Grant funds from the Vet-LIRN network to acquire a digital PCR system to increase capacity of and capabilities for SARS-CoV-2 diagnostic testing in animals. This equipment will enhance digital PCR capacity, which is more sensitive than traditional real-time PCR approaches and allows for target quantification. This equipment will enhance the One Health mission by providing sensitive and quantifiable results to veterinarians and stakeholders to detect and diagnose SARS-CoV-2 in animals.